The Neu-Lung Consortium: Neutrophilic Mechanisms of Inflammation, Injury, and Repair in Lung and Airways Diseases

PROJECT SUMMARY/ABSTRACT – OVERALL
Neutrophils are abundant immune cells that are recruited from the circulation in response to inflammation,
infection, and injury. In the lung and airways, neutrophils serve as critical innate immune effectors of the host
defense against pathogens yet also drive serious and important diseases with enormous

Public health relevance
PROJECT NARRATIVE – OVERALL Neutrophils are abundant yet poorly understood immune cells that drive lung diseases with enormous public health relevance. We hypothesize that cellular and humoral signals originating from the circulation and from specific niches within the injured lung microenvironment drive heterogeneous neutrophil phenotypes and functions that determine the balance between inflammation, injury, and repair in patients with neutrophilic lung and airways diseases. The Neu-Lung Consortium brings together experts in fundamental immunology, respiratory disease, clinical medicine, and computational biology who will synergize to test mechanistic hypotheses of neutrophilic disease pathogenesis using cutting-edge technologies applied to human lung, airway, and blood samples obtained from well-phenotyped patients with pneumonia, primary lung allograft dysfunction, and asthma.